SINGLE CRYSTAL XAS STUDIES ON O2 ACTIVATING HEME PROTEINS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We propose to investigate two heme proteins involved in O2 binding using solution and single crystal XAS spectroscopy. The first study will be on cytochrome c peroxidase, which catalyzes the two-electron reduction of H2O2 to water. The reduction of H2O2 proceeds via the formation of two high-valent heme intermediates;compound I and compound II. We plan to study compound I using single crystal Fe K-edge XAS and EXAFS to determine the rate of photoreduction and the concomitant change in the EXAFS signal (specifically the Fe-O bond). These studies will be extended to compound II of CCP to understand differences in the geometric and electronic structure between the two high-valent states. The XAS data will be coupled to DFT (density functional theory) and Fe K-pre-edge time dependent-DFT calculations, which will help shed light on the intermediates formed in the catalytic mechanism of H2O2 reduction by CCP. In the second study we propose to investigate the electronic structure of oxyhemoglobin using a combination of Fe K-pre-edge analysis and time-dependent DFT calculations. The data will be correlated to deoxyhemoglobin, methemoglobin and heme model complexes to accurately distinguish between the following possible electronic configurations of the [(heme)Fe-O2] species present in oxyhemoglobin: i) low-spin S=0 FeII + singlet S=0 O2, ii) an intermediate-spin S=1 FeII + triplet S=1 O2 (antiferromagnetically (AF) coupled) and iii) a lowspin S=1/2 FeIII + S=1/2 O2 - (superoxide).